Core--Administration and Statistics

The administrative and biostatistical core will manage the budgetary, administrative and statistical aspects of the Program Project Grant (Program). The Core will be responsible for coordinating meetings and interactions among investigators on the Program, transmitting data within the Program, communicating with NIAID program personnel, preparing publications and maintaining a bibliography describing work performed under the Program, and all financial matters relating to the Program. A statistician will provide expertise in analyzing the significance of our experimental data. An administrative manager will provide liaison with the hospital's financial office, office of research affairs, materials management, and will coordinate travel.